Investigator Development Core

Investigator Development Core
Summary
The previous 50 years have seen a revolution in the conceptual
approaches and scientific tools to investigate the brain and behavior. This has
led to explosive growth in our knowledge and understanding of the brain,
increased clinical applications for that knowledge, and the growth of neuroscience as a discipline. Our
expanding knowledge is also broadening the scope of the field of neuroscience and spinning off exciting
new disciplines such as neuroethics, social neuroscience, neuroimmunology, and neuromicrobiology.
Continued progress in growing our knowledge about the brain and establishing Delaware as an important
contributor to that progress requires expanding the state’s pool of neuroscience investigators who can lead
creative research programs and be competitive for independent grants.
The mission of our Investigator Development (ID) Core is to expand the capacity of the universities
in our Delaware Neuroscience Center to support neuroscience research by preparing a cadre of investigators
competitive for NIH Research Project Grants and other funding for neuroscience research at multiple scales,
from human subjects to rodent and invertebrate models. Our Neuroscience Center will carryout its mission
by: 1) Establishing a competitive pilot grant program that will allow early stage researchers to generate
preliminary data to support competitive grant proposals related to neuroscience; 2) Fostering the
productivity, advancement, and retention of neuroscience researchers by providing a robust professional
development infrastructure to support publication of peer-reviewed articles, submission of grant proposals,
and development of strong professional networks; 3) Establish a framework for planning and preparation
of multi-investigator R01 and program project grants.
We will leverage PI Harrington’s experience supporting the maturation of early stage faculty
through directing phase I and II of our COBRE Center, the institutional connections and mentoring
infrastructure that was developed as part of those awards, and the network of support for biomedical
researchers created by the IDeA-funded programs INBRE, CTR and COBREs. This Core will develop
both early stage investigators with the pilot grant program and established investigators by helping them
connect with potential collaborators and expand the scope of their research.

Public health relevance
Delaware Center for Neuroscience Research Public Health Relevance Summary The foundation of Phase III proposal is Delaware’s expanding set of human and research resources in neuroscience, which has Delaware neuroscience research competitive on a national level. Our project supports research aimed at determining how thoughts, memories, feelings and actions emerge from dynamic activities in the brain and are changed over time; as well educational programs to develop a workforce that can participate in and benefit from advances in our understanding of brain function. An increased understanding of how the brain and nervous system functions will facilitate treatments for diseases and injuries and provide insights into human behavior, biases, and cognition.